Intestinal Lymphocyte Trafficking

SUMMARY:
The GI tract recruits lymphocytes from the blood to establish an immune barrier to pathogens, while enforcing
tolerance to self and, after birth, to food antigens and enteric bacteria. "Natural" (unconventional) thymus-
derived T cells of the intraepithelial compartment (IEL) comprise the most abundant T cell pool in the adult and
neonatal intestines, and yet how they are recruited to the colon and small intestines, why they populate the GI
tract before birth, and their roles in epithelial homeostasis and pathogen resistance in the perinatal period
remain incompletely understood. The objective of the current proposal is to define mechanisms of innate-like T
cell trafficking to the GI tract in fetal and perinatal life, and to establish the role(s) of these receptors, and of the
specialized IEL T cell subsets they control, in intestinal development and immunity.
In Aim1 we will identify the major innate T cell subsets in the mouse fetal intestines, determine the
chemoattractant receptors that recruit them into the SI and colon from the thymus, and define their function in
the prenatal gut environment. We will manipulate fetal T cell recruitment in vivo and perform organoid co-
culture ex vivo to test the hypothesis that specialized fetal T cells drive maturation of the intestinal epithelium
and program epithelial defenses in preparation for birth. In Aim 2 we will establish the importance of these
mechanisms and T cells in pathogen responses in models of neonatal viral and bacterial infection. In Aim 3 we
will identify human innate T cell counterparts of the major mouse fetal colon T cell, as defined by common
developmental trajectories; shared gene programs, homing receptor profiles and cytokine responses; and
common functions in intestinal epithelial differentiation. We will employ innovative approaches and develop
new protocols and tools to address these aims. Results from these studies will significantly advance our
understanding of the cells, pathways and mechanisms that prepare the fetal GI tract for microbial assault at
birth. These insights could lead to novel diagnostic, therapeutic or preventative strategies targeting neonatal
immunity.

Public health relevance
PROJECT NARRATIVE Balanced immunity in the gastrointestinal tract is essential to health, and imbalance contributes to inflammatory bowel disease (IBD), cancer, allergic, and metabolic disorders. Our studies identify new mechanisms and cells and their roles in establishing the gut immune system to protect newborn babies against viruses and bacterial infections, and to prevent inflammatory bowel disease, allergic and infectious diseases in adults. The results will improve our understanding of a healthy mucosal immune system, and could provoke novel preventative, therapeutic treatment strategies or cures for these infectious and inflammatory diseases.